Structure-based in-silico prediction of peptide interactions.

Interactions between peptides and their substrates play a central role in many cellular processes and computational
methods, such as automated docking, are used to gain a mechanistic understanding of these interactions. While docking
small molecules works well, peptide-docking remains a challenging, relatively new, and fast evolving field with direct and
high translational impact. We have been at the forefront of developing physics-based peptide-docking methods. Emerging
deep learning methods (DL) such as AlphaFold are deeply impacting structural biology and have recently been shown to
perform well for predicting protein-peptide interactions. We propose to further develop and enhance cutting-edge
approaches for the prediction of peptide interactions with their binding partners, with a special focus on expanding
coverage of the chemical space of building blocks used to synthesize therapeutic peptides. To this end, we will extend our
state-of-the-art peptide docking software program AutoDock CrankPep to support non-standard amino-acids, and
additional peptide cyclization modes. We will also develop novel scoring functions specifically designed for peptide
docking. Furthermore, physics-based and DL-based peptide docking methods are complementary and we have evidence
that they can be synergistically combined to leverage their respective strengths. These combined docking strategies will
further extend the range of biological questions and biomedical targets for which peptide docking can be applied. Finally,
we will extend peptide-docking methods for predicting peptide-peptide interactions. Such a method will have a
significant impact on the development of peptide-based therapeutic approaches.
We will continue to collaborate with experimental biologists as the biological systems they study challenge our software
tools and drive their development and extension with new methods. Furthermore, these collaborations provide us with
data beyond the traditional benchmark datasets for validating and refining our computational methods and predictions.
These collaborations span from translational applications such as the development of vaccines against the flue or
molecules used to prevent brain damage in stroke patients, to pioneering the use of computational structural biology
approaches to study small Open Reading Frame (smORFs) encoded polypeptides, an exciting emerging new frontier in
biology.
We have a long-standing track record of promoting diversity in our research team, of implementing best practices in
software development, and producing and distributing production-grade, open-source software, widely used by large and
growing and diverse community. The software tools resulting from this project will be developed and distributed using the
same principles, supporting the research of many medicinal chemists and biologist and extending their use to an even
wider community. These software programs will support the preclinical design of peptide-based therapeutic molecules
and approaches, thereby supporting the advancement of biomedical research as well as fundamental aspects of structural
biology.

Public health relevance
Automated docking is a workhorse for rational drug design, however, applying these methods to peptides has remained challenging, thus impeding the rational designing of peptide-based therapeutic approaches. We have been at the forefront of the development peptide-docking docking methods with our state-of-the-art physics- based docking engine, AutoDock CrankPep (ADCP), which can successfully dock linear and cyclic peptides with up to 20 standard amino acids, and we have established that AlphaFold2 multimer and ADCP can be combined to achieve higher docking success rates. We will further develop ADCP to support more therapeutic peptides; synergistically combine it with AlphaFold2 multimer; and explore the use of these protein-peptide docking methods for approaching peptide-peptide docking, yielding docking tools that will impact the research of many computational and medicinal chemists and biologist, contribute to our understanding of biological processes, and significantly advance biomedical research.